Bioinformatics and Biostatistics Core

Core B: Bioinformatics and Biostatistics Core SUMMARY/ABSTRACT
The primary goal of the Bioinformatics and Biostatistics Core is to provide centralized biostatistics,
bioinformatics, and database support for all SPORE projects and cores, ranging from basic science studies to
animal studies to genomics studies to clinical trials. The Core will serve multiple needs for the planning and
conduct of the SPORE's translational research. Based on a strong track record of providing biostatistical support
for translational research, the Core will be a comprehensive, multilateral resource for designing clinical and
basic science experiments, performing statistical analyses, developing innovative statistical methodology, and
publishing the research results generated from the SPORE. The Core will confer regularly with project
investigators to discuss the design and conduct of research projects, evaluate results of analyses, discuss
potential new research initiatives and directions within the SPORE, and promote the publication of findings.
To serve all proposed SPORE Projects, as well as the Career Enhancement and Developmental Research
Programs, the Bioinformatics and Biostatistics Core has the following specific aims:
Specific Aim 1: Provide statistics and data analyses required for the Projects and Cores to achieve their specific
aims;
Specific Aim 2: Provide bioinformatics expertise required for analyses and interpretation of high-throughput
assay data;
Specific Aim 3: Assist with design and implementation of new trials and studies arising from SPORE research;
Specific Aim 4: As necessary, to develop and adapt innovative statistical and bioinformatics methods pertinent
to ovarian cancer studies.